Drug Overdose Testing: A Data Collection and Reporting Emergency

The overdose epidemic is driven by illicit fentanyl and fentanyl analogues, often combined with synthetic simulants. The
addition of new psychoactive substances (NPS), a broad classification of new substances constituting a diverse range of
chemicals including stimulants and hallucinogens as well as research chemicals related to benzodiazepine and opioid
classes, to the illicit drug market further complicates the drug supply. People who use drugs want to know what is in their
drugs and will adjust their use and take more preventative actions in response. Unfortunately, the ability to test, detect and
report substance exposure including NPS at overdose accurately within the healthcare system does not exist given current
clinical toxicology testing protocols. The Emergency Department (ED) standard for drug exposure evaluation is urine drug
screen testing (UDS). UDS has limitations in analytical selectivity and scope which can lead to incorrect provider
assumptions regarding drug exposure. Additionally, UDS omits evaluation of NPS and other pharmaceuticals, including
active cut, that can increase overdose risk, resulting in an incomplete picture of drug exposure and supply safety. Our goal
is to evaluate current toxicology testing protocols in the Emergency Department to positively impact patient, provider, and
public health outcomes including clinical care, drug supply surveillance, and harm reduction outreach. The specific aims for
the proposed study are: (1) Evaluate the utility of standard hospital UDS to test for drug exposure in the evolving drug
supply dominated by illicit synthetics via comparison to liquid chromatography quadruple time-of-flight mass spectrometry
(LC-QTOF-MS) toxicology testing; (2) Determine whether LC-QTOF-MS toxicology testing results from ED non-fatal drug
overdose cases match findings in post-mortem toxicology testing from drug overdose fatalities using the Rhode Island
State Unintentional Drug Overdose Reporting System (SUDORS) to assess future application for early drug supply
biosurveillance; and (3) Measure feasibility and acceptability to patients of biological drug checking feedback using
toxicology testing results after an ED visit for drug-overdose. We will enroll 100 ED patients with non-fatal unintentional
drug overdose at Rhode Island Hospital over one year comparing toxicology testing results from a standard-of-care
hospital UDS protocol to LC-QTOF-MS. Results of LC-QTOF-MS toxicology testing in non-fatal drug overdose will then be
compared to toxicology testing results from unintentional opioid-involved drug overdose fatalities (SUDORS) to evaluate
whether toxicology testing results from non-fatal drug overdoses treated in the ED reflect substances causing overdose
death. We will also evaluate the feasibility and acceptability of incorporating detailed toxicology data into harm reduction
efforts. Enrolled patients will be provided results of comprehensive toxicology testing results from the time of non-fatal
drug overdose and complete a follow up acceptability survey on the service. Together these aims can inform local, state,
and national illicit drug supply surveillance efforts, improve patient outreach and guide future hospital protocols for
drug-overdose toxicology testing.